3rd Annual Forum for Improving Children's Health Care

[unreadable] DESCRIPTION (PROVIDE BYAPPLICANT): The National Initiative for Children's Healthcare Quality (NICHQ) requests support from the Agency for Healthcare Research and Quality (AHRQ) for Large Conference Support for the Annual Forum for Improving Children's Health Care. The objectives of the Forum for Improving Children's Health Care are to: [unreadable] [unreadable] 1. Build will for improvement in care by highlighting successful evidence-based models and interventions (will) [unreadable] 2. Disseminate strategies for implementing valid findings of health services research (ideas) [unreadable] 3. Provide the basis for collaboration and information sharing related to child health care across the multiple stakeholder levels affecting children's health care (execution) [unreadable] 4. Develop faculty for future initiatives intended to improve quality of health care for children (execution and building capacity) [unreadable] [unreadable] This is the only conference that focuses specifically on improving the quality of health care services for children, spanning the continuum of health care delivery and clinical content areas. The conference attracts leaders in all aspects of children's health care with the capacity to influence system performance. It provides an effective vehicle for communicating findings of health services research and translating those findings into practice. Funding from the agency will enable the Forum to reach a larger audience by increasing attendance in its targeted market, by enhancing the quality of the conference presentation through use of appropriate technology, and by preparing materials for dissemination through print and electronic media. [unreadable] [unreadable]